Enzymeless, controlled electrostatic ratcheting in solid-state nanopores

This is a diversity supplement to the parent award seeking to support an LGBTQ+ graduate student, an
underrepresented group in the biomedical sciences.

Public health relevance
While further the goals of the parent award, this diversity supplement will help to increase representation of LGBTQ+ people in STEM.